"NIAAA ALCOHOL EPIDEMIOLOGIC DATA SYSTEM (AEDS)" RESEARCH AND DEVELOPMENT SUPPORT SERVICES PROVIDING STATISTICAL ANALYSIS AND PROGRAMMING SUPPORT TO NIAAA STAFF CONDUCTING ALCOHOL-RELATED EPIDEMIOLOGI

"NIAAA ALCOHOL EPIDEMIOLOGIC DATA SYSTEM (AEDS)" RESEARCH AND DEVELOPMENT SUPPORT SERVICES PROVIDING STATISTICAL ANALYSIS AND PROGRAMMING SUPPORT TO NIAAA STAFF CONDUCTING ALCOHOL-RELATED EPIDEMIOLOGICAL STUDY.